Center for multidimensional atlas of the human heart

PROJECT SUMMARY - OVERALL
The human heart presents remarkable anatomical, cellular and functional heterogeneity, with specialized
cellular structures performing distinct yet essential physiological functions. A significant gap of knowledge is
that different cells’ molecular signature, spatial distribution and interactions, and functional state remain little
understood for the heart. We therefore propose the in-depth characterization of the heart which accounts for a
large fraction of human disease burden. We will map molecular and cellular changes in heart tissues over the
course of human lifespan using comprehensive multi-dimensional single-cell and imaging technologies. The
final product will impact research of the heart in the following manner: 1) Organ Atlases: spatially resolved
atlases will provide a highly user friendly, publicly available, searchable database of the most comprehensive
multi-omic, single cell analysis of the heart. Molecular data will be richly annotated with additional clinical and
epidemiological data. 2) Computational methods: in addition to the data, the critical computational tools and
pipelines developed in this project will be available to the research community. These include methods and
pipelines for processing multi-omics and imaging data, inference of cell-specific regulatory and signaling
pathways, correlation of mesoscale imaging and molecular imaging features, as well as database algorithms
for the query, exploration and visualization of highly complex data. 3) Access to biospecimens for follow-up
studies: biospecimens collected in this project will be banked and made available to the biomedical research
community. These include freshly frozen and fixed specimens and tissue sections. In summary, the proposed
project will broadly impact the entire research community and jumpstart basic-science and medical discoveries
based on a sophisticated understanding of the key molecular circuits underlying the development and aging of
the heart.

Public health relevance
PROJECT NARRATIVE - OVERALL The heart is a vital organ for human health. Our in-depth characterization of this organ will lead to improved understanding of heart diseases and has the potential to greatly change the outcomes landscape of these heart diseases.